Probing conformational dynamics of HIV-1 Env in real time and in situ during virus entry

Research Abstract: The envelope (Env) glycoprotein is a virus-encoded protein exposed on the surface of HIV-
1 virions and is the primary target of neutralizing antibodies against HIV-1. Env is structurally flexible or
conformationally dynamic, allowing HIV-1 to enter susceptible cells via membrane fusion and evade antibody
recognition. Thus, the highly dynamic Env is a critical target for developing HIV-1 vaccines, inhibitors, and cure
strategies. However, a lack of knowledge on the structural dynamics of Env entangles the attempts to
comprehend the mechanisms by which Env enables virus entry and facilitates immune evasion, which is at the
core of Env-directed interventions. Env is a trimer in which each protomer consists of two subunits, gp120 and
gp41. The surface-exposed gp120 contains receptor/coreceptor binding sites, and the transmembrane gp41
harbors the fusion machinery. Upon binding to the receptor CD4, gp120 undergoes conformational changes that
lead to the exposure of a coreceptor-binding site. Subsequent interactions with the coreceptors will then activate
a cascade of fusion-promoting refolding events in gp41, progressing from a metastable pre-fusion state, through
the putative pre-hairpin intermediates, to the stable post-fusion six-helix bundle that leads to the fusion of viral
and cellular membranes. High-resolution structures of Env have significantly furthered our understanding of Env
architectures and antigenicity during virus entry. However, real-time conformational dynamics of Env that
delineate the sequence of events that underlies the structural transformations and the fusogenic transitions
remain largely elusive. Single-molecule Förster resonance energy transfer (smFRET) was applied upon
introducing FRET-paired fluorophores into gp120 to reveal the dynamic features of virus-associated full-length
Env. We have demonstrated that native Env is dynamic and, upon interaction with CD4, transitions from the pre-
triggered conformation (State 1) through a partially open intermediate (State 2) to the fully activated open
conformation (State 3). Many broadly neutralizing antibodies (bNAbs) demonstrate a preference for State 1-Env.
Unexpectedly, the designed soluble Env, the detergent-solubilized Env, and the aldrithiol-2 inactivated virus-
associated Env all exhibit a propensity to occupy State 2, offering a different perspective on the current spectra
of Env-based vaccine design. Our studies on gp120 using smFRET have set the stage for our next goal—to
investigate the less-understood fusion protein gp41. Specifically, we propose to use the dynamic-and-static in-
situ imaging platform of smFRET and cryo-electron tomography (cryoET) to directly visualize real-time
conformational dynamics/events of virus-embedded gp41 that correlate with membrane fusion and characterize
potential drug-targeting gp41 intermediates structurally. The ultimate goal is to generate a fusion movie serving
as the framework for developing HIV-1 interventions that direct against virus entry. We will also use our platform
to specify conformational recognition preferences for virus-associated Env of gp41-directed neutralizing
antibodies to inform the development of antibody cocktails and the “antibody-to-vaccine” strategy.

Public health relevance
Narrative The mechanism by which HIV-1 surface spike protein - envelope (Env) enables virus entry via viral membrane fusion and facilitates immune evasion is at the core of Env-directed interventions against HIV-1. Our proposed work will reveal temporally and spatially precise molecular details of HIV-1 Env during viral membrane fusion and specify the recognition mode of antibodies for Env conformations/structures, providing mechanistic insights into HIV-1 virus entry and virus neutralization by antibodies. These insights will guide the rational design of Env- targeting interventions, such as immunogens for vaccines and small molecule inhibitors, to block virus entry.